RI's Plan to Develop, Implement, and Sustain an All-hazards Food Emergency Rapid

Summary/Abstract Title: Food Protection Rapid Response Teams (U18) Funding Opportunity Announcement Number (FOA): RFA-FD-12-013 The Rhode Island Department of Health proposes to develop, implement, and sustain an all-hazards food emergency Rapid Response Team (RRT) that conforms with the Best Practices identified by other Rapid Response Teams already in place in other states. We plan to train and prepare staff to effectively respond to foodborne outbreaks, document results, identify potential preventive practices, and make changes based on lessons learned. The team will also investigate high risk foods that are manufactured in RI and work with the manufacturer to improve the process and reduce the risk of foodborne illness. Activities performed under this grant will protect public health and decrease the number of people who become ill by addressing the outbreak/emergency more efficiently and effectively. Implementing a Rapid Response Team will strengthen intra-agency and interagency collaboration, both to improve effectiveness of multi-agency responses and to build programs on nationally shared best practices and tools.

Public health relevance
Project Narrative Title: Food Protection Rapid Response Teams (U18) Funding Opportunity Announcement Number (FOA): RFA-FD-12-013 Foodborne outbreaks and other food emergencies contribute to the more than 48 million foodborne illnesses that CDC estimates occur in the United States each year. This grant response will develop, implement, and sustain a Rapid Response Team to address outbreaks and other food-related emergencies. Having a Rapid Response Team trained to meet best practices will allow RI to respond to food emergencies more efficiently and effectively, which will ultimately protect public health and decrease the number of people who become ill. __SpecificAimsTextDelimiter__ RI Department of Health Grant Application for Food Protection Rapid Response Teams (U18) FOA: RFA-FD-12-013 Overview of Specific Aims The Rhode Island Department of Health (HEALTH), Office of Food Protection (OFP), is committed to food safety and protecting public health. One mechanism by which HEALTH protects public health is by responding to foodborne outbreaks and other food emergencies. Our goal is to improve our response to food emergencies by acting more rapidly and effectively in order to identify the cause, implement control measures, and ultimately prevent additional individuals from becoming ill. Aim 1: Develop a Rapid Response Team The RI Department of Health aims to develop, implement, and sustain an all-hazards food emergency Rapid Response Team (RRT) that is based on nationally shared best practices and tools. The team of diverse individuals with expertise in various areas of food safety will be trained to standards described in RRT Best Practices Manual so they will be prepared to effectively and efficiently respond to food emergencies. Aim 2: Collaborate with Partners on Rapid Response Team Activities The RI Department of Health aims to collaborate with federal and state partners (RI has no local health departments), epidemiology and laboratory counterparts within the RI Department of Health, and other RRTs to develop the RRT and support RRT activities. Aim 3: Assess Rapid Response Team Capabilities The RI Department of Health aims to assess the capabilities of the RRT by comparing the concepts, elements, and metrics to those described by FDA's Division of Federal-State Relations (DFSR). Lessons learned from these assessments will be incorporated into program improvement plans. Aim 4: Incorporate Rapid Response Team Concepts into Existing System The RI Department of Health aims to integrate the Rapid Response Team concept and capabilities into the existing structure of the Office of Food Protection. We will develop a mechanism to leverage funding so that these Rapid Response Team capabilities can be maintained indefinitely beyond the end of the project period. Aim 5: Implement and Exercise Rapid Response Team Capabilities The RI Department of Health aims to implement the Rapid Response Team capabilities not only by responding to actual food-related emergencies, but also by participating in tabletop exercises. These activities will identify strengths and weaknesses of the RRT and will allow the RRT to focus their efforts on areas that need improvement in order to strengthen response capabilities. Aim 6: Document Rapid Response Team Activities The RI Department of Health aims to document the RRT response to food emergencies in a transparent manner, and identify prevention practices that can be implemented in the future. Reports will be shared with FDA and posted on the website.